Role of Arginase 1 in Retinal Ischemia-Reperfusion Injury

PROJECT SUMMARY
Retinal ischemia is a major cause of vision loss in common retinal disease conditions including diabetic
retinopathy, glaucoma, retinopathy of prematurity, and vein occlusion. This project aims to define the
mechanisms of retinal ischemic injury and identify new therapeutic targets.
My long-term career goal is to pursue a distinguished career in vision research and academia. I will
achieve this through establishing a strong independent research program in an academic institution that
promotes interdisciplinary biomedical science and translational research. My short-term goal is to attain intensive
training and supervised career development skills that are required for my career transition to become an
independent investigator. Securing this award will provide me with the necessary training to achieve my short-
term goals and will be the first step towards independence and achieving my long-term goals.
My mentor's lab has demonstrated the involvement of the arginase enzyme in retinal neurovascular
diseases. Arginase has two isoforms. Building upon the lab's finding that the mitochondrial isoform, arginase 2
(A2), has a deleterious role in retinal ischemia-reperfusion (IR) injury, I developed a project focusing on the
neurovascular protective role of the cytosolic isoform arginase 1 (A1). My recently published paper shows a
neuroprotective role of A1 expression in myeloid cells. Arginase competes with nitric oxide synthase (NOS) for
their common substrate L-arginine. Nitric oxide (NO) produced by inducible NOS (iNOS) causes neurovascular
degeneration. I predict that A1 upregulation in myeloid cells limits iNOS-derived nitrative and oxidative stress
and reduces inflammation through its downstream metabolites ornithine and putrescine. Putrescine is the
precursor of polyamines and it is formed from ornithine by ornithine decarboxylase (ODC, the rate-limiting
enzyme in polyamine biosynthesis). These metabolites have been shown to promote reparative myeloid cells
through chromatin modification. In line with this, my preliminary data show that histone deacetylase (HDAC) 3 is
increased in the absence of A1 in both IR-injured retinas and stimulated macrophages. HDAC3 is essential for
macrophage inflammatory gene transcription and it has been shown to suppress A1 expression. Herein, I
propose a novel suppressive effect of A1 on HDAC3. My central hypothesis predicts that myeloid A1 protects
against retinal IR injury through ODC-mediated suppression of HDAC3. I will be using mice with myeloid-specific
deletion of A1, ODC and HDAC3, as well as the investigational drug, BCT-100 (a PEGylated form of arginase
1), together with primary macrophages isolation and treatment with inhibitors for HDAC3 or arginase downstream
enzyme, ODC. My goal is to achieve the following objectives: A) Determine the effect of manipulating the
arginase pathway on myeloid cells infiltration / activation in retinal IR injury and the therapeutic potential of BCT-
100. B) Describe the cross talk between the arginase pathway and HDAC3 and determine whether A1 in myeloid
cells mediates its protective effect through suppression of HDAC3.

Public health relevance
PROJECT NARRATIVE This project is in line with the NEI mission to support research studying visual disorders and their mechanisms. It aims to enhance our knowledge of the mechanisms underlying retinal ischemic diseases including diabetic retinopathy, glaucoma, retinopathy of prematurity, and vein occlusion. Moreover, the project has the potential to translate the cross talk between the arginase pathway and histone deacetylase 3 in myeloid cells as a new therapeutic target for these retinal disorders.